Imposing order on the family of ubiquitin-conjugating (E2) enzymes through intracellular perturbation with nanobodies

Abstract
The ubiquitin-proteasome system affects almost every aspect of eukaryotic cell biology. Ubiquitin conjugation is
organized in a highly hierarchical manner, with a family of ~40 E2-type ubiquitin conjugating enzymes interposed
between one or two E1-type ubiquitin-activating enzymes and literally hundreds of E3 ubiquitin ligases, the latter
charged with substrate modification. The multiplicity of E2s and the many E3s they serve has made it challenging
to sort out their individual contributions to the overall process in living cells: most of what is known for the
properties of E2s is based on in vitro experiments. In this proposal I will therefore fill this gap in our knowledge
and study the in vivo properties of the E2 family. I will apply new methods to deliver E2s -in thioester linkage with
a tagged ubiquitin- into living cells, a goal not previously within reach, to probe their contributions to the overall
process of ubiquitylation. Using mice genetically modified for the purpose, I will further develop a suite of antibody
fragments that will be used to control and direct interactions of the different E2s intracellularly in ways not
previously possible. The focus of my proposal is thus on an in vivo analysis of ubiquitylation, using a newly
developed toolkit that will find application in other areas of biology. Single domain antibody fragments (VHHs or
nanobodies) are the smallest immunoglobulin-derived fragments that retain antigen binding properties. Currently
their production revolves around the use of camelids as the only natural source of heavy chain-only antibodies,
from which VHHs are then derived. VHHs are unusual, in that they can be expressed in the cytosol as single
chains with retention of antigen binding properties. Consequently, they can be used to disrupt intracellular protein-
protein interactions, or to enforce interactions between proteins that would not occur on their own accord. These
properties I will exploit to manipulate the above E2s and the reactions in which they participate, especially in the
context of the inflammatory response. I propose to engineer mice such that they are capable of producing heavy
chain only antibodies as a source of VHHs, thus eliminating the need for immunization of the larger and more
cumbersome llamas, camels or alpacas. Screening for antibody fragments with suitable properties will employ a
novel bacterial two-hybrid screening procedure to maximize the likelihood of obtaining single domain antibodies
that can recognize and modulate E2s in living cells.
While my approach is centered on E2s, it will serve as an example of how standard genetic approaches
(mutagenesis; deletion; shRNA; Cas9/CRISPR) can be complemented by methods that leave the target proteome
intact, instead relying on exogenously introduced biologicals (VHHs or nanobodies) as molecular perturbants.
The ability of VHHs to serve as crystallization chaperones ensures that the consequences of such perturbations
can be understood at molecular, if not atomic resolution. This concept is obviously transposable to any complex
pathway of interest. Therein lies an additional pioneering element of this proposal.

Public health relevance
Narrative The present proposal seeks to develop a new mouse model to serve as a source of single domain antibody fragments, which will be used to perturb and control protein-protein interactions. I will apply these tools, together with a new delivery and screening platform, to untangle the web of E2-type ubiquitin ligases that govern the ubiquitin-proteasome pathway.